Project 3: Identifying Targetable Epigenetic and Immuno-Oncologic Vulnerabilities in Synovial Sarcoma

RP3: Identifying Targetable Epigenetic and Immuno-Oncologic Vulnerabilities in Synovial Sarcoma
ABSTRACT
Synovial sarcoma (SS) is driven by SS18::SSX-dependent chromatin dysregulation, suggesting that elucidating
key aspects of this deregulation might point to therapeutic epigenetic vulnerabilities. At the same time, driver
fusions such as SS18::SSX may generate a unique class of shared, or public, neoantigens because they create
novel peptide sequences that diverge significantly from self-proteins. Specifically, the junctional amino acid
sequence of the chimeric SS18::SSX proteins is unique to SS cells. In addition, there is evidence that epigenetic
modulation may potentiate immunotherapy approaches. Thus, our overall goal is to identify epigenetic and
immuno-oncologic vulnerabilities in SS and potential synergies between them towards an overall goal of long-
term responses in metastatic SS. To accomplish this, our multidisciplinary research team of experts in cancer
genomics and epigenetics, T cell immunobiology and immune-peptidomics, and clinical trials in pediatric and
young adult sarcomas will pursue 3 specific aims. Aim 1 is to decipher H3K36 methylation-dependent crosstalk
and vulnerabilities in SS, on the basis of our clinical genomic profiling data on SS identifying recurrent loss of
function in histone 3 lysine 36 (H3K36) methyltransferases (e.g. SETD2) in ~10% of cases. In isogenic cell lines,
we will determine how decreased H3K36me3 affects the genomic localization of SS18::SSX and fusion protein-
dependent transcriptional programs and establish the key determinants of DNA methylation and polycomb-
mediated chromatin domains. We will validate these observations in prospectively collected patient-derived
tissues and xenografts (PDXs). Finally, we will identify SETD2-/--specific dependencies in SS using a chemical
probe approach; resulting hits will be studied mechanistically and validated in both PDXs and isogenic SETD2-/-
models. Because epigenetic mechanisms are important tumor-intrinsic mediators of immune escape, we will
also explore whether SETD2 loss affects SS immunogenicity. Aim 2 is to measure the immunogenicity of an
SS18::SSX public neoantigen and test the antitumor efficacy of T cells genetically engineered with a T cell
receptor recognizing it. Specifically, we will define the HLA-restricted immunogenic peptides resulting from the
SS18::SSX fusion protein, retrieve the TCR α/β gene sequences associated with SS patient-derived T cells that
recognize such peptides, and validate that cloned TCRs confer fusion-derived reactivity and tumor regression in
vivo when retrovirally transduced into a polyclonal T cell population. In Aim 3, we will determine the tolerability,
immunogenicity, and antitumor efficacy of a multivalent mRNA vaccine encoding the SS18::SSX(1/2) junction
sequence and multiple cancer-testis antigens (CTAs) highly expressed in SS, in combination with an anti-PD-L1
antibody, via a phase I/II clinical trial in collaboration with Moderna and TRACON. Correlative analyses
associated with the trial will measure how the vaccine affects the T cell response to polypeptides containing the
above sequences and resolve the HLA restriction and TCR clonotypes for T cells responding to the SS18::SSX
fusion and CTA sequences.

Public health relevance
RP3: Identifying Targetable Epigenetic and Immuno-Oncologic Vulnerabilities in Synovial Sarcoma NARRATIVE This project will develop and evaluate new treatment strategies for synovial sarcoma by (1) examining how a specific genetic alteration affects epigenetic regulation and identifying anticancer drugs that target the resulting vulnerabilities, (2) developing an engineered T cell-based therapy to recognize the protein resulting from the fusion of two genes that occurs only in synovial sarcoma, and (3) evaluating the efficacy and immunogenicity of an mRNA vaccine designed to induce immune responses to the fusion protein and other synovial sarcoma- specific antigens, in combination with an immune-modulating antibody in a clinical trial.